Chemical probes for imaging and treatment of otitis media

Project Summary
Otitis media (OM), or infection of the middle ear, is the second most common illness diagnosed in children in
the United States. It results in greater than $2 billion in costs per year and is responsible for 24% of all pediatric
antibiotic prescriptions. Acute OM is most commonly caused by the bacteria Streptococcus pneumoniae,
Haemophilus influenzae, Moraxella catarrhalis and Staphylococcus aureus, with Pseudomonas aeruginosa
being the most common cause of chronic OM. Diagnosis of OM currently relies on otoscopy, which has low
sensitivity and specificity and is unable to differentiate bacterial infection from viral infection or other causes of
inflammation. These limitations result in over-diagnosis and over-prescription of antibiotics which contributes to
growing antimicrobial resistance (AMR) and subsequent treatment failures. Therefore, there is a significant
unmet need for improved diagnostic tools for OM that can enable faster and more effective treatment decisions
while also reducing the potential for AMR development. We propose to address these current shortcomings in
OM diagnosis and treatment by developing chemical probes that will enable initial imaging to confirm an
infection and then immediate treatment using phototherapy, thus avoiding the use of antibiotics. We will focus
on the bacterial D,D-carboxypeptidases (DD-CPases), a class of proteases involved in processing of
glycopeptides in the cell membrane to facilitate formation of the bacterial cell wall. These proteases are ideal
imaging targets as they are active and present within the outer cell membrane, can be targeted with small
molecule inhibitors that form covalent bonds to the active site and exist only in bacteria. Our central hypothesis
is that a probe carrying a fluorescent phototherapy dye that covalently labels the bacterial DD-CPases of the
five major OM-causing bacteria will enable specific detection of OM by fluorescence imaging and then effective
treatment through simple and non-toxic light exposure. In support of this hypothesis, all five common OM-
causing bacteria have a DD-CPase that lack human homologs and have conserved actives sites suitable for
covalent inhibition. Moreover, recent evidence suggest that PDT can be used as an effective antibacterial
treatment strategy. Therefore, we will accomplish our goal of identifying a novel diagnostic and treatment
strategy for OM through completion of the following primary aims: Aim 1: Develop a covalent active site probe
that targets the DD-CPases of the five primary OM-causing bacteria. Aim 2: Demonstrate that a single covalent
probe can be used to image and kill the five most common OM-causing bacteria in vitro. Aim 3: Use validated
probes from in vitro studies to confirm imaging and clearance of each of the five common OM-causing bacteria
in a mouse model of OM.

Public health relevance
PROJECT NARRATIVE This project outlines plans to develop imaging probes that selectively and permanently bind to the five primary bacteria that cause otitis media, a common infection of the middle ear. The primary goal is to create new tools that will enable rapid diagnosis and treatment to prevent the overuse of antibiotics that facilitates the formation of multidrug resistant bacteria.